UTSW-UNC Center for Cell Signaling Analysis

ABSTRACT
Cellular behavior is regulated by diverse signaling mechanisms that often depend on molecular dynamics
precisely organized in space and time. The transient positioning and kinetics of molecular events is lost in bulk
biochemical analysis and in single cell proteomics. Understanding such factors requires visualization and
quantitative analysis of molecular events in living cells and tissues, now made possible by combining molecular
probe design, high-resolution live cell microscopy and computational image analysis. However, combining these
diverse technology into a working whole for the quantitative analysis of live cell signaling networks remains
challenging. The proposed Center for Cell Signaling Analysis aims to democratize advanced methods that
put these tools in the hands of scientists who have not devoted their careers to imaging. We propose to develop
and disseminate a user-friendly and integrated pipeline that combines 1) biosensors, optogenetics and
chemogenetics 2) modular, high-speed, and high-resolution light-sheet microscopes, and 3) image analysis and
computational modeling to derive signaling network architecture, including the causality and kinetics of
connections. The Center will concentrate its integration effort between 3 Technology Development Projects:
i) Optogenetics, chemogenetics, and biosensors based on alternate approaches with complementary
capabilities and reduced perturbation of signaling.
ii) Multiple modular, cost-effective, and high-resolution 3D light-sheet microscopes that can be
assembled rapidly by non-experts and deliver ~220 and ~450 nm lateral and axial resolution. These
will be designed to maximally leverage computer vision workflows, biosensors, and
optogenetics/chemogenetics.
iii) A library of open-source Fiji-based plugins for the analysis of subcellular signal transduction in 2D
and 3D live cell time-lapse data using advanced methods in statistical time series analysis.
Through our collaborative Driving Biological Projects (DBPs), we will iteratively refine and improve our probes,
imaging platforms and image analysis methods. We have identified 8 DBPs that address topics in immune cell
migration, immunological synapse function, mechanosensation, sarcomere formation, cancer dissemination and
drug resistance, synaptic plasticity, and ventral furrow ingression. We propose a strong dissemination
component that maximally leverages existing infrastructure, including imaging facilities with >3,000 users
located throughout the United States, the widely adopted Fiji software ecosystem, Addgene, GitHub, and Applied
Scientific Instrumentation. We will provide extensive training (in person, remote, and topic-driven courses) and
centrally organize the Center outputs on a comprehensive and continuously updated website.

Public health relevance
The proposed Biomedical Technology Development and Dissemination Center aims to consolidate and distribute imaging-based technology for the study of cellular signals. The Center will combine computer vision, light-sheet microscopy, and advanced imaging probes to visualize, control, and model molecular activities at the level of microns and seconds. The technology will be tested and refined in diverse biological systems and disseminated to the greater scientific community in partnerships with microscopy core facilities and established distribution platforms (Addgene, GitHub, ImageJ/Fiji, Applied Scientific Instrumentation).